Administrative Core

Administrative Core B is an integral core activity serving the following purposes: 1) to provide both fiscal and administrative support for the 3 component projects and for Scientific Core A. 2) to coordinate and facilitate the interactions that connect all 3 projects and Scientific Core A 3) to organizeand sponsora formal program review in year 2 4) to organize bi-monthly meetings of project leaders and a yearly Migraine Program Project retreat. 5) to facilitate communications between the PI and Internal Advisory Committee.